Elucidating the Mechanism in the Regulation of RNA-binding Phase Separation

The project summary is included in the two-page Research Strategy document.

Public health relevance
Project Narrative Liquid–liquid phase separation of proteins and nucleic acids drives the biogenesis of diverse membraneless organelles with important biological functions. Dysregulated phase separation of RNA-binding proteins leads to the formation of toxic fibrils, which is a pathological hallmark in multiple fatal neurodegenerative diseases. Elucidating molecular mechanisms of phase separation regulation and developing strategies to reverse aberrant phase transition and fibrillization will lay the foundation for advances in novel therapeutic strategies to combat these fatal diseases.